Career Development of Environmental Health Investigators

The Career Development program is directed by Dr. Joseph Graziano, the founding director of CEHNM, first as a P20 (1994), then as a PSO (1998) Center. Dr. Graziano also served as Chairman of the Department of Environmental Health Sciences for 13 years, and as Associate Dean for Research for seven years, during which time he recruited and mentored many junior faculty who have gone on to have strong, independent research programs in environmental health, including several of our current CEHNM members (i.e., Drs. Factor-Litvak, Gamble, Kinney, and Orjuela). He has also mentored more than 20 PhD students who have gone on to successful careers in academia, government (EPA, FDA) and the pharmaceutical industry.